The role of pyruvate kinase as a therapeutic target in T-ALL

ABSTRACT
T-cell acute lymphoblastic leukemia (T-ALL) is an aggressive hematologic malignancy that occurs
primarily in children but can also occur in adults. Despite recent advances in treatments, 20-50% of
patients do show primary resistance or relapse after treatment and ultimately die from their disease,
highlighting the need to discover novel targeted therapeutic approaches. The detection of highly
prevalent NOTCH1 activating mutations in T-ALL, seen in ~60% of patients, led to the discovery of
NOTCH1 signaling inhibitors such as gamma-secretase inhibitors (GSIs), that block a critical
proteolytical cleavage step required for NOTCH1 maturation and activation. GSIs are currently being
explored in clinical trials for relapsed/refractory cases, however, the responses observed as a single
agent treatment have been generally limited, such that the identification of novel targets and
combination therapies capable of delivering strong and synergistic antileukemic responses in patients
is one of the most urgent goals in the T-ALL field. Our lab has previously demonstrated the therapeutic
benefit of targeting metabolic routes in T-ALL. In this context, my preliminary results strongly
suggest that targeting the glycolytic enzyme pyruvate kinase (PKM) has strong antileukemic
effects on its own, and significantly synergizes with GSI treatment in vivo. Still, the role of PKM in T-
ALL remains largely unknown. Notably, PKM has two different isoforms, PKM1 and PKM2, and we
have already generated conditional knockout leukemias for each specific isoform, as well as for both
of them concomitantly, which will allow us to exquisitely analyze the effects of pyruvate kinase in
leukemia progression and response to therapy in vivo. Thus, the aim of this project is to
mechanistically dissect the function of PKM in T-ALL by using a combination of gene expression,
metabolomic profiling, epigenetic profiling and experimental therapeutics in vivo, taking advantage of
our unique genetic tools. Our results will shed light on the mechanisms by which NOTCH1 controls
cancer cell metabolism and will reveal PKM as a putative novel target for the treatment of T-ALL.

Public health relevance
PROJECT NARRATIVE T-Cell Acute Lymphoblastic Leukemia (T-ALL) is a disease where relapses occur in 20-50% of cases, and these patients ultimately die from their disease, highlighting the need to discover novel therapeutic targets. Our preliminary results have identified pyruvate kinase (PKM) as a novel therapeutic target in T-ALL, thus, here we will address the role and mechanisms of PKM in T-ALL in vivo taking advantage of our unique genetic and technical tools. Our results will pave the way for improved therapeutic approaches for the treatment of T-ALL patients in the short-term.